The effects of skull malformations and intracranial hypertension on the glymphatic and meningeal lymphatic systems in craniosynostosis

Abstract:
Our work has shown that humans with craniosynostosis, the second most prevalent craniofacial disorder, have
skull and cerebrovascular malformations that cause intracranial hypertension (i.e. raised pressure). The effects
of raised intracranial pressure on cerebrospinal fluid (CSF) circulation and fluid balance in the central nervous
system are unknown in craniosynostosis, a notable gap in the field. Our new findings in craniosynostosis animal
models suggest that skull dysplasia and raised pressure impair CSF flow, brain perivascular waste clearance
pathways (the glymphatic system), and the development of meningeal lymphatic vessels. Infusing fluorescent
tracers into CSF reveals significant changes to circulation pathways, and less influx into brain tissue and outflow
to surrounding meningeal lymphatic networks. Meningeal lymphatics, which grow in dura attached to the skull,
are hypoplastic and less complex. Interestingly, highly branched segments specialized for CSF uptake and waste
removal, known as “hotspots”, are poorly developed and/or missing. These novel findings are significant because
the brain's glymphatic system and supporting meningeal lymphatic vessels are necessary to prevent β-amyloid
plaque buildup and cognitive impairment. Collectively, these data form a central hypothesis; craniosynostosis
causes raised intracranial pressure and altered CSF hydrodynamics that impair the development and functions
of both the glymphatic and meningeal lymphatic systems. This, in turn, affects the clearance of waste and β-
amyloid from the brain. We test this hypothesis using our innovative systems biology approach that integrates
skull development with intracranial pressure, CSF flow, and the brain's glymphatic and lymphatic systems. In
Aim 1, we use two genetic mouse models for craniosynostosis to test if impaired glymphatic (i.e. CSF) influx and
efflux impede the clearance of β-amyloid oligomers injected into the brain. Next, we test if the clearance of β-
amyloid plaques is reduced by generating mouse models for craniosynostosis and amyloid deposition that
express five mutations found in familial Alzheimer's disease. We also test a mechanistic basis for glymphatic
dysfunction in craniosynostosis, by examining if the polarization of Aquaporin-4 water channels to glial endfeet
is perturbed. These glial (i.e. glymphatic) water channels facilitate CSF flow through perivascular spaces in the
brain, and therefore waste exchange between CSF and brain interstitial fluid. In Aim 2, we test whether
meningeal lymphatic deficits affect waste drainage to the cervical lymph nodes. We also explore a molecular
mechanism for meningeal lymphatic deficits by testing if VEGF-C expression and the activation of VEGFR3
receptor signaling is affected. Collectively, our novel system and approaches can dissect interlocking
mechanisms through which normal skull development controls CSF flow, brain waste clearance pathways, and
meningeal lymphatic drainage. This work has profound clinical significance as deficits in glymphatic waste
exchange and meningeal lymphatics in craniosynostosis may imply increased risks for β-amyloid plaque buildup
and neurocognitive impairment.

Public health relevance
Project Narrative: Craniofacial disorders that affect the development of the skull can cause elevated intracranial pressure and abnormal cerebrospinal fluid circulation. We will test the hypothesis that elevated intracranial pressure and abnormal cerebrospinal fluid circulation in craniosynostosis perturbs the development and functions of meningeal lymphatic vessels and the brain's perivascular waste clearance system, hindering the removal of beta-amyloid and leading to plaque buildup in the brain.